DoD Reagent Transfer

The objective of this IAA is to develop critical reagents (to include inactivated antigenic materials, nucleic acids and antibodies) for use in basic research and product development activities for Category A-C pathogens.